Novel therapeutic development for small cell lung cancer

PROJECT SUMMARY / ABSTRACT
Small cell lung cancer (SCLC) is characterized by rapid growth, early dissemination, and exceptionally poor
prognosis. The Rudin laboratory has focused on the study of SCLC for over 2 decades using a fully integrated
platform of basic discovery and clinical translational research. Our laboratory has driven fundamental advances
in the understanding and characterization of SCLC. We have excelled in successfully translated many
discoveries made by our group into clinical testing, including many active trials currently being conducted by our
clinical team. Closing the circle, we are also deeply engaged in the molecular characterization of biospecimens
from patients receiving these novel therapies, to better inform new directions of laboratory research while
maintaining direct disease relevance. In this R35 we will focus primarily on three main areas of future focus for
our group. (1) Recent extensive single cell profiling data from our laboratory has defined the exceptional intra-
and inter-tumoral heterogeneity of primary human SCLC. We have identified a key subpopulation with stem-like
capacity, present in tumors of all SCLC subtypes, and also identified and characterized a novel tumor-infiltrating
macrophage subtype exclusively associated with SCLC. The stem-like cell population expands progressively in
nodal and distant metastases, and high fraction of this subpopulation confers a strikingly poor clinical prognosis.
Defining, characterizing, and targeting these novel cell types could have a transformative impact on patients with
SCLC. (2) We have a long-standing interest in lineage plasticity, including histologic transformation from lung
adenocarcinoma to SCLC, and tumor evolution between SCLC subtypes. We now have multiple relevant tools
in hand to dissect the biology of lineage plasticity in lung cancer, including patient-derived xenograft (PDX)
models of lung adenocarcinoma that under different conditions transition to different subtypes of SCLC. We will
deeply analyze the drivers of SCLC transformation as a mechanism of tumor escape and acquired resistance in
lung cancer. These data will inform approaches to prevent or restrict lineage plasticity as a driver of therapeutic
resistance. (3) We have developed new technology allowing controlled in vivo CRISPR/Cas9 gene editing in
PDX. We will adapt this system to conduct focused SCLC genetic dependency screens in vivo using a guide
RNA library covering the druggable genome. Applied across all subtypes of SCLC, this approach will define
novel therapeutic targets for this recalcitrant malignancy.

Public health relevance
NARRATIVE This grant focuses on novel therapeutic approaches to address small cell lung cancer, an exceptionally lethal disease, using multiple emerging technologies including single cell profiling and novel disease models based on direct modification of human tumors by genome editing in vivo. We will define and target a newly identified stem- like tumor subpopulation we have identified, analyze and target lineage plasticity as a mechanism of acquired drug resistance, and conduct screens to identify new and tractable therapeutic vulnerabilities in human small cell lung cancers.